White Matter Toxicity and Neurocognitive Outcomes in Pediatric Brain Tumor Patients Treated with Proton Beam Radiation Therapy

PROJECT SUMMARY/ABSTRACT
Most children treated for cancer in the US will achieve long-term survival, and survivorship presents unique
challenges for this growing population. Brain tumor survivors are at particular risk for a range of functional
impairments, including cognitive, educational, and social difficulties. Cranial radiation therapy is an essential
lifesaving treatment but is associated with cognitive decline. Proton beam radiation therapy (PBRT) is one of
the most promising recent advances in pediatric brain tumor treatment. The proposed medical advantage of
PBRT lies in the precision of radiation delivery with proton beams, depositing maximum dose to clinical targets
while minimizing radiation to surrounding tissues. By eliminating unnecessary radiation to surrounding healthy
brain tissue, PBRT may spare cognitive functioning better than conventional photon or x-ray irradiation (XRT).
Using volumetrics and diffusion tensor imaging (DTI), we will examine associations between white matter
(WM) toxicity and neurocognitive outcomes in pediatric brain tumor patients treated with PBRT. Study 1 is a
prospective, longitudinal study of WM change and associated neurocognitive outcomes in pediatric brain tumor
patients treated with PBRT vs. Surgery Only followed from diagnosis through Early Survivorship. Specific aims
include: (1) to compare change in WM volume/integrity over time by treatment group (PBRT vs. Surgery Only
and vs. healthy controls (HCs)), and (2) to examine associations between WM toxicity and neurocognitive test
scores over time. Study 2 is a cross-sectional study of associations between WM and neurocognitive
outcomes during Intermediate Survivorship for pediatric brain tumor survivors treated with PBRT vs. Surgery
Only with the following specific aims: (1) to compare WM volume/integrity in survivors by treatment type (PBRT
vs. Surgery Only and vs. HCs), and (2) to examine associations between WM toxicity and neurocognitive test
scores. Study 3 is a cross-sectional study of WM associations with neurocognitive outcomes during Late
Survivorship for pediatric brain tumor survivors treated with PBRT vs. XRT including the following specific
aims: (1) to compare WM volume/integrity in survivors by treatment group (PBRT vs. XRT and vs. HCs), and
(2) to examine associations between WM toxicity and neurocognitive test scores.
This proposal is consistent with NCI's objective to “reduce the long-term adverse effects of cancer and its
treatment” in children and to “improve the quality of life for cancer patients, survivors, and their families.”
Neurocognitive late effects lead to significant educational, social, and occupational limitations for many
survivors, greatly affecting their quality of life and functional independence long-term. Research is needed to
determine which treatments are best able to limit the suffering associated with post-treatment neurocognitive
decline. Our results will have clinical value, providing a timely report of WM correlates of neurocognitive
functioning and comparison between treatment modalities.

Public health relevance
PROJECT NARRATIVE Many consider proton beam radiation therapy (PBRT) to be a promising treatment for children with brain tumors as it may preserve cognitive functioning without sacrificing disease control. Currently, there are no published studies assessing white matter toxicity and associated cognitive change in patients treated for pediatric brain tumors with PBRT. Ultimately, this line of research is intended to: (1) help physicians and families better understand the effect of PBRT on brain tissue and cognitive functioning to inform treatment decisions, and (2) provide functional outcome data to be used toward justifying or reconciling the high cost and access limitations currently associated with PBRT.